Lake Ontario Center for Microplastics and Human Health in a Changing Environment

ABSTRACT: Human health is inextricably tied to the Great Lakes, which hold 20% of the Earth’s surface
freshwater. Climate change is impacting the Lakes, altering water temperature, pH, storm frequency, ice cover,
and precipitation. Human debris, including plastic, also impacts the Lakes and those who rely on it. Plastic enters
the Lakes as microplastic (MP; particles <5 mm) or as macrodebris that may degrade to MP. There are significant
knowledge gaps about the cycle of plastic in the Lakes, but MPs have been found in all lake habitats, throughout
the food chain, and in tap water. The potential human health effects of Lake-associated exposure to MP are
vastly understudied. How MP inputs and impacts will be affected by climate change is also unknown. Addressing
such complex problems requires engaging diverse community partners and a multidisciplinary systems science
approach. The over-arching goal of the Lake Ontario Center for Microplastics and Human Health in a Changing
Environment is to prevent negative human health impacts of MP in the context of climate change in the Great Lakes
by engaging diverse partners in research, promoting environmental health literacy, and promoting solutions.
Because the Lake Ontario region is representative of the Great Lakes basin, our work will be broadly transferable.
Our innovative approach assesses plastics as they exist in the environment: as mixtures of post-consumer plastic
polymers, degraded by the environment, and covered with biofilm. A major challenge of MP research is
standardization of materials and methods, which we address with a novel Materials and Metrology Core that
supports and is integral to all 3 research projects. Project 1 will holistically assess projected climate
change impacts on plastic input, degradation, ecotoxicity, and microorganisms in plastic-associated biofilms.
Project 1 culminates in modeling to predict future input, fate and transport of microplastics in Lake Ontario.
Project 2 will build on Project 1’s foundation to assess the potential for dermal and lung exposure to MPs by
leveraging nanomembrane technologies to analyze mammalian cytotoxicity and bioactivity of natural and
experimental particle mixtures in combination with variation in temperature and availability of metals and
persistent organic pollutants. Project 3 extends the investigation to the whole organism by using the
amphibian Xenopus to rigorously assess the biodistribution of MPs and impacts on development, fitness,
immune homeostasis and antiviral immunity, under varied conditions of temperature. Given the high degree of
evolutionary conservation of vertebrate physiology, the outcomes from this study are very relevant to human
health. Our Community Engagement Core involves diverse partners in all aspects of the Center, including
community science, direct action, development and dissemination of materials, and building partners’ capacity
to promote solutions. Our Administrative Core coordinates across two institutions (the University of Rochester
and the Rochester Institute of Technology), supports multidirectional communication with external stakeholders,
oversees our Plan for Enhancing Diverse Perspectives, and evaluates progress toward Center goals.

Public health relevance
OVERALL NARRATIVE The Lake Ontario Center for Microplastics and Human Health in a Changing Environment aims to prevent negative health impacts of microplastics in the context of climate change in the Great Lakes region. Our multidisciplinary systems research integrates assessment of sources, transport, fate, and impact of anthropogenic debris into Lake Ontario, with experimental investigation of biological activity of real-world mixtures of microplastics, associated biofilms, and other chemical contaminants utilizing novel nanomembrane technology. Multidirectional engagement with diverse partners will support community science, environmental health literacy, and capacity to promote multilevel solutions.